Contraceptive DMPA-induced bone loss: A novel source of toxic metal lead exposure in young women

PROJECT SUMMARY/ ABSTRACT
The primary objective of this proposal is to examine an unintended consequence of depot medroxy-
progesterone acetate (DMPA) induced bone loss: increased circulating toxic metal lead levels. DMPA is an
important contraceptive option used by millions of women worldwide, including 54% of contracepting women in
Uganda. However, an established side effect of DMPA use is bone loss, with the greatest bone mineral density
(BMD) decline occurring during the first two years of use. We hypothesize that the skeletal effects of active
DMPA use increase the release of lead stored in bone to plasma, resulting in increased circulating lead levels.
Chronic exposure to lead is common worldwide, with high community lead exposure occurring in thousands of
locations across the U.S. and globally, including Uganda. As over 90% of lead from exogenous exposure is
stored in bone, bone becomes an endogenous lead source. Lead is mobilized to plasma, particularly during
periods of higher bone turnover and loss. Plasma contains the most biologically active fraction of lead in
circulation. No safe levels of lead exist; even at low doses, lead adversely affects all organ systems, due to its
ability to replace calcium ions. The DMPA-lead association has only been tested in two cross-sectional studies,
with both studies reporting an association. We propose to prospectively investigate DMPA use and circulating
lead levels by building on the NICHD-funded Kampala Women’s Bone Study (KWBS) (R01HD089843, PI:
Renee Heffron). KWBS, a 2-year longitudinal study of 499 women ages 16-25 years in Uganda, is investigating
the impact of concurrent initiation of DMPA and tenofovir HIV pre-exposure prophylaxis (PrEP) on bone loss.
Participants completed study visits every 3 months and were monitored with dual energy x-ray absorptiometry
(DXA) scans of BMD and trabecular microarchitecture annually and markers of bone turnover, estrogen, and
vitamin D at 5 time points over 24 months. Leveraging archived specimens, we will measure these markers at
4 additional time points to yield quarterly measurements. As lead measured in urine is indicative of bioactive
circulating (plasma) lead, we will measure urinary lead concentrations every 3 months over 24 months. We will
use this extensive data to achieve the following aims: (1) assess whether adolescent and young women
initiating DMPA (n=268) have higher circulating lead levels compared to condom users (n=231) over 24
months; (2) investigate the mechanism of bone remodeling and loss on lead release from bone to plasma with
DMPA use. We will examine in DMPA users and non-users quarterly bone remodeling indices, annual lumbar
spine and total hip BMD, annual trabecular bone score, and quarterly estrogen levels and lead level change
over 24 months; and (3) explore whether greater dietary calcium intake and sufficient vitamin D status reduce
skeletal mobilization of lead to plasma. This robust prospective study builds on NICHD’s commitment to
understanding the effects of contraception on human health, including DMPA-induced bone loss, and will
generate vital data to inform the provision of safer contraception in adolescent, adult, and lactating women.

Public health relevance
PROJECT NARRATIVE Depot medroxyprogesterone acetate (DMPA) is an important contraceptive option for the prevention of unintended pregnancy for millions of women globally. However, the well-established side effect of increased bone turnover and bone loss with DMPA use may mobilize toxic metal lead stored in bone to plasma, exposing DMPA users to increased circulating lead levels. Given that chronic exposure to lead from water, air, food, and dust is common, no safe levels of circulating lead exist, and strong evidence that lead negatively affects health, the information gleaned from the proposed project will inform the provision of safer contraception in adolescent, adult, and lactating women.